Principal Project

The COVID19 pandemic illustrates the urgent need for understanding human B cell responses to emergent pathogens and its application to assessing herd immunity. Our laboratories have described the phenotypic, immunological and molecular features of different arms of human B cell responses and in particular, the original characterization of the human extrafollicular effector B cell activation pathway and its contribution to different memory and plasma cells responses. On that basis, we we propose to interrogate the different arms of the B cell response to the SARS-CoV-2 virus; to identify the B cell compartments that participate in the early, ongoing and late post-infection responses; and to determine their contribution to the establishment of herd immunity, at least in part through the generation of protective B cell memory. The latter is an essential feature that could be uncoupled from the persistence of serum antibodies; and therefore, would go unrecognized unless formally tested. We postulate that the establishment of cellular B cell memory and the ability to evaluate its magnitude and quality will be critical to track the risk of the population to short-term re-infection and seasonal exposure; to design vaccines capable to trigger this protective feature; and to develop SARS-CoV-2 B cell-based diagnostic tests. These goals will be accomplished using blood samples from SARS-CoV-2-infected and convalescent individuals through the following specific aims: Aim 1. Characterization of SARS-CoV-2-specific B cell responses through multidimensional B cell flow cytometry A precise adjudication of the cellular origin, magnitude, and persistence of the anti-SARS-CoV-2 B cell response will be accomplished by antigen-specific flow cytometry and validated by multiplex antigen assays and single cell analysis of the B cell populations. Aim 2. Measurement of SARS-CoV-2-specific B cell memory and herd immunity. Phenotypic features and antigen-specific flow cytometry assays established in aim 1, will be applied to intermediate and late post-infection time points in order to understand: a) the cellular compartments in which SARS-CoV-2-specific B cell memory resides; b) its quality, magnitude and distribution within the population; c) its provenance (whether from early of late cellular precursors); and d) its concordance or conversely, uncoupling from serological responses and the generation of long-lived plasma cells (LLPC).

Public health relevance
Studying the B cell responses to the SARS-CoV-2 virus will be essential for our understanding of the course of the COVID19 pandemic; the development of immunological memory and the distribution of herd immunity in the population. We will perform a detailed characterization of the B cells responsible for the generation of antibody responses to the COVID'19 virus and their ability to identify patients that developed long'term protection. We will also apply our B cells assays to determine the spread of immune responses in the general populations thereby providing an assessment of the degree of herd immunity.